MUSC SCORE Leadership Administrative Core

ABSTRACT
The Leadership Administrative Core (LAC) is the backbone of the MUSC SCORE operations. As it has in
previous funding periods, the LAC will continue to provide the organizational framework for addressing emergent
issues, budgetary concerns and daily operations within the SCORE. It will also ensure the integration of the
SCORE within MUSC, with local and statewide officials and community treatment centers, and across the
national consortium of SCOREs. The LAC will (1) provide fiscal and administrative management for all program
components; (2) provide scientific and programmatic leadership; (3) manage the SCORE Pilot Project Program;
(4) support campus-wide, regional, and national cross-SCORE collaborations; and (5) oversee the SCORE
Evaluation Program. During the next funding period, the LAC will build on its previous successes to expand the
MUSC SCORE's functionality as a valuable regional and national resource on sex and gender differences in
addictive disorders through establishment of a Women's Health Research Consortium, expansion of MUSC's
Women's Health Research Day, and strategic partnership with statewide treatment providers.

Public health relevance
PROJECT NARRATIVE The Leadership Administrative Core (LAC) is the hub of the MUSC SCORE, serving as the central coordinating point for all SCORE activities. It influences each of the research projects and Center cores, and brings the various components together to form a cohesive, functioning unit. The LAC also oversees SCORE outreach, collaboration, and evaluation efforts.